Foxo transcription factors are required for maintenance of acute myeloid leukemia

7. PROJECT SUMMARY/ABSTRACT: AML is a blood cancer that arises from the uncontrolled expansion of immature white blood cells. AML patients display an extraordinarily high rate of mortality, with only 23% surviving beyond 5 years. This poor prognosis results from both a high incidence of leukemia relapse and the ineffectiveness and toxicity of current therapies. While these alarming realities demand the development of more effective AML chemotherapies, this notion is complicated by two major factors. First, a small but distinct fraction of leukemia cells (called leukemia-initiating cells or LICs) are able to evade conventional drugs and cause leukemia relapse. Second, AML has many different sub-types, each with different genetic abnormalities that limit the ability to design broad-spectrum anti- AML drugs. Therefore, identifying and targeting common molecular irregularities specifically found in LICs is a critical basis for developing successful broad-based AML therapies. Using a gene expression dataset derived from a large human AML sample set, we have identified that the FOXO family of genes are inappropriately activated in ~40% of AML cases. Using a mouse model of AML we also found that FOXOs are critical regulators of LICs. Further investigation revealed that approximately 60% of the leukemic samples were resistant to FOXO suppression. Those cells that were FOXO insensitive had abnormalities of another pathway, the JNK gene family. Inhibition of both FOXO and JNK, using drugs to inhibit JNK enzymes, resulted in marked killing of even the resistant cancer cells. We now aim to determine the downstream effectors of the FOXO and JNK pathways that allow these genes to promote leukemogenesis. Specifically, we will examine how the activities of the oncogenes c-JUN and β- catenin are affected by manipulation of the FOXO and JNK pathways. Further, we want to evaluate whether pharmacological exploitation of these pathways provides a proof-in-principal strategy for the treatment of AML. We will accomplish this by evaluating how the combined inhibition of FOXO and JNK signaling impacts human AML cell growth and LIC function. We believe that these proposed experiments align perfectly with the National Cancer Institute's mission to uncover new molecular signatures in human cancer that could improve diagnostic tools and provide platforms for the design of new, more effective anti-cancer therapies. Additionally, addressing these questions will: 1. Further define the unrecognized role of FOXO and JNK signaling pathways in cancer biology. 2. Provide novel proof-of-concept strategies for the treatment and diagnosis of AML. 3. Improve our understanding of the molecular networks that support human leukemogenesis in vivo.

Public health relevance
PROJECT NARRATIVE: Acute myeloid leukemia (AML) is a blood cancer that kills 3 out of 4 diagnosed patients. The high mortality of AML is the cumulative result of frequent disease relapse (caused by rare cells called leukemia-initiating cells (LICs)), insufficient targeted (or specific) therapies and the high toxicity of conventional chemotherapies. We have identified two gene families, FOXOs [fox¿o] and JNKs [junk] that are ideal targets for the design of novel anti-leukemia therapies because combined these genes are aberrantly active in the LIC populations of the majority of AMLs. __SpecificAimsTextDelimiter__ 10. SPECIFIC AIMS: Acute myeloid leukemias (AMLs) are hematopoietic cancers that display a high incidence of relapse and generally have a poor prognosis (5-year overall survival rate of 23.6%)1. The extensive genetic complexity observed among individual AMLs and the persistence of leukemia-initiating cells (LICs) in large part contribute to the low overall survival rate and poor efficacy of current AML therapies2-5. Identifying and characterizing molecular signatures that regulate LIC function across a broad-spectrum of genetically diverse AMLs is a critical first step in unveiling points of vulnerability for the rational design of tailored anti-leukemia therapies. We have discovered that the FOXO family of transcription factors support LIC function and are active in a multitude of genetically diverse AMLs. Specifically, gene set enrichment analysis (GSEA) of a large primary AML patient microarray dataset (n=436) reveals that FOXOs are active in approximately 40% of AMLs6, 7. Furthermore, genetic ablation of FoxOs in an established murine model of AML8 significantly delays the onset of leukemia (p=0.0009) and reduces the frequency of LICs 16-fold6. Biologically, we have determined that inhibition of FOXOs decreases leukemic burden by promoting differentiation and subsequent cell death of human and murine AML cells6. At the molecular level, we see that the phosphorylation and expression of the stress-activated kinase JNK and its downstream substrate c-JUN increase with FOXO inhibition both in vitro and in vivo6. Additionally, co- administration of the pan JNK inhibitor, SP600125 potentiates the anti-leukemic effects of FOXO inhibition in vitro suggesting that JNK pathway activation allows leukemia cells to tolerate diminished FOXO activity6. In support of this idea, we observe that c-JUN expression inversely correlates with FOXO activity in primary human AML (p<0.0001)6. We hypothesize that specific events in the JNK signaling pathway modulate the survival of AML LICs through regulation of FOXO function. We further predict that rational strategies targeting these events in pre-clinical models of AML will be an effective means of controlling disease progression. Since the oncogene β-catenin has previously been shown to influence FOXO and JNK/c-JUN signaling under separate circumstances, we hypothesize that β-catenin and FOXOs directly antagonize one another to regulate JNK/c-JUN signaling in AML. Therefore, we propose the following Specific Aims: 1. Determine the components of the JNK signaling pathway that tolerate FOXO inhibition in AML. 2. Assess the effects of combining FOXO inhibition with the JNK inhibitor, SP600125 on leukemogenesis in vivo. 3. Investigate the relationship between FOXO and β-catenin signaling. ! ! !